Acquisition of 700 MHz NMR Spectrometer

DESCRIPTION (provided by applicant): Funding is requested to purchase a 700 MHz NMR spectrometer for biological applications in solution for installation at the New York Structural Biology Center (NYSBC), a consortium of nine research institutions in New York State. The requested 700 MHz NMR spectrometer is essential to the over- riding purpose of the NYSBC to support the particular aims of the NIH-funded research of the major and minor users of the spectrometer and will replace a highly used instrument that is no longer available to NYSBC and its member institutions. A 700 MHz NMR spectrometer fills an essential niche at NYSBC, allowing multi-field spin relaxation studies and facilitating optimal usage of higher field 800 and 900 MHz instruments by matching particular experiments to the most appropriate field strengths. Research conducted on the 700 MHz instrument ranges from fundamental studies of structure/function of biomolecules, to elucidation of mechanisms of pathogenesis, to discovery of novel lead compounds to pharmaceutical applications.

Public health relevance
PUBLIC HEALTH RELEVANCE: The New York Structural Biology Center (NYSBC), a consortium of nine research institutions in New York State, houses and supports all of the ultra-high field (>600 MHz) NMR spectrometers used by scientists at member institutions. NMR spectroscopy is a critical method used across biological research conducted at member institutions and maintaining state-of-the-art instrumentation is essential to the mission of NYSBC. The requested 700 MHz NMR spectrometer is essential for magnetic-field-dependent studies and will enable research ranging from understanding fundamental biological processes in normal and pathological states to discovery of potential new drugs for treatment of cancer and other diseases.